Administration

The overall goal of the Administrative Core is to provide scientific leadership and a framework for support services to ensure accomplishment of the research and educational missions of the Center. The Aims of this Core are to provide leadership and management for the Center in four broad areas: 1) Research; 2) Training; 3) Dissemination; and 4) Collaborations. To achieve these aims, the Administrative Core functions in the planning, evaluation, and oversight of scientific activities, the provision of sound fiscal management and the coordination of research projects, scientific cores, and training activities. It assures effective clerical, information technology (IT) and library services, promotes career enhancement opportunities, and provides opportunities and resources for participation in the dissemination and translation of findings. With the Center Management Group, the Core develops collaboration with researchers at national and international levels. It fosters an intellectually lively, multi-disciplinary climate of discovery, one stimulated by enrichment activities from visiting experts who help us keep connected to advances elsewhere. This proposal for the continuation of the Alcohol Research Group’s (ARG) National Alcohol Research Center in the Epidemiology of Alcohol Problems will involve continued leadership from Dr. William C. Kerr, who has successfully led the Center since 2016. Principal Investigator and Scientific Director Kerr will be assisted by Dr. Nina Mulia who will be the Associate Director in the new Center, with responsibilities for greater coordination of research across Center components and support for dissemination and collaboration. Dr. Kerr will assume responsibilities for training in conjunction with leadership of the affiliated NIAAA T32 Training Grant and including research career mentoring and leadership of the Center’s enrichment program. PI Kerr and Dr. Mulia are joined in the Center Management Group by Component Directors Dr. Priscilla Martinez, Dr. Camillia Lui, Dr. Libo Li, Dr. Won Kim Cook, and former Center Director Dr. Thomas Greenfield and former Center Associate Director Dr. Cheryl Cherpitel. The Management Group will ensure that Center components and the ARG’s independent grants are well integrated and interact productively, marshalling resources and seizing scientific opportunities where they arise. The Management Group serves as a steering committee for the Center, meeting monthly to provide regular updates on Cores and Projects, oversight of research quality, and monitoring of the timely execution of proposed activities and the achievement of Aims.